REGENERATION AND TRANSPLANTATION OF SKELETAL MUSCLE

The common theme of this program project is the regeneration and transplantation of mammalian skeletal muscle. There are four major areas of emphasis in the program: 1) Reintegration of regenerating muscle with the vascular and nervous systems of the host; 2) regulation of genetic expression and protein synthesis in regenerating muscle; 3) devising means of improving the mass of muscle that can be transplanted and improving the functional properties of a given regenerated muscle; 4) in vivo evaluation and prediction of the structure and function of grafted models. Emphasis of component projects is as follows: Daniel Axelrod - dynamics and localization of acetylcholine receptors; Kate Barald - interactions between regenerating muscle and nerve fibers in vitro; Bruce Carlson - interactions between regenerating muscle and nerve in vivo; John Faulkner - revascularization of regenerating muscle; Carl Gans - electromyographic evaluations of the structure and function of regenerating muscle. George Jones - regulation of protein synthesis in regenerating muscle; Jessica Schwartz - hormonal regulation of muscle regeneration; Timothy White - effects of physical conditioning on regenerating muscle.